Subcontract Project/Moffitt/Theoretical/Experiment

During the last 5 years, as we learned how to integrate experimentation with the single mathematical model (HDC) we originally focused on, we gradually expanded into other types of models. We have developed a suite of mathemafical and computational models that consider different spafial and temporal scales of tumor progression, so that their applicafion is dictated by a specific biological quesfion. The resolufion and scope of each model is largely driven by the specific aspect of tumor progression we are considering in the Projects